The Mouse Model System for Targeted Trimming of Disease Susceptibility Loci

SUMMARY
The identification of genes responsible for a particular trait or disease, as well as genes that affect phenotypical
presentation of the primary mutation (gene modifiers) is one of the major goals of biomedical science. This
usually involves mapping the susceptibility locus first, followed by pinpointing the causative gene. Susceptibility
loci are commonly identified through association studies in humans, and backcrossing and comparison of
recombinant strains in mice. Such loci are usually quite large, spanning several mega base pairs and
containing multiple genes, often with no obvious relevance to the phenotype in question. Furthermore, genes
for non-coding RNAs, as well as intergenic regulatory elements, often unknown, can influence expression of
genes far away from the susceptibility locus, making their identification even more challenging. Overall, the
identification of the causative gene within susceptibility locus and therefore, the development of new
therapeutics based on the disease mechanism may become a rather remote possibility. We propose to
streamline this task by targeted trimming of susceptibility loci through homologous recombination induced at
specified locations. Implementation of this approach will require generating two new mouse lines that will be
subsequently crossed to reconstitute all required components. This will provide a reliable, time- and cost-
efficient route to mapping causative mutations, allowing mechanistic studies of the disease.

Public health relevance
PROJECT NARRATIVE Understanding the mechanism of disease is required for developing effective therapeutics, and identification of responsible genes is the first step in this process. Although many disease susceptibility loci have been determined for numerous conditions, pinpointing the causative genes within such loci may take years, if not decades. We propose to develop the new approach to streamline this task.